Systems immunology of influenza vaccination responses in healthy COVID-19 recovered individual versus those with no history of COVID-19

This year we finalized analyses using data on samples collected in FY 2020 and FY 2021 as part of IRB-approved protocol 19-I-0126. These samples were from 33 individuals with prior mild COVID-19 and 40 age- and sex-matched healthy controls with no history of COVID-19. These data types include flow cytometry, assay for transposase-accessible chromatin using sequencing (ATAC-seq), RNA sequencing (RNA-seq), and cellular indexing of transcriptomes and epitopes by sequencing (CITE-seq). These finalized analyses were included in a manuscript published in the journal Nature.